Biobehavioral Intervention to Reduce PTSD Symptoms After an ICD Shock

ABSTRACT
This study, “Biobehavioral Intervention to Reduce PTSD Symptoms After an ICD Shock,” addresses a critical
need in cardiology care by describing the feasibility and acceptability of a timely, highly promising,
electronically-delivered intervention for patients who have recently received an ICD delivered shock. The study
intervention and outcomes are designed to reduce anxiety, enhance return to activities of daily living (ADLs),
and prevent the development of severe distress and post-traumatic stress disorder (PTSD), and ultimately
promote quality of life. The study is a two-arm, embedded mixed methods, randomized trial (N=60, 30/group).
The purpose is to determine feasibility and potential effects of a self-management intervention (SPSM) plus
usual care (UC) compared to UC alone, delivered during the critical 1 month period after an ICD shock when
distress is high. The intervention will be delivered over 1 month following an ICD shock; a 6-month follow-up
will be used to assess the sustainability of intervention effects and determine if the incidence of PTSD is
reduced. SPSM includes: 1) training in heart rate (HR) self-monitoring; and 2) individualized learning through 4
self-paced, web-based modules. The study interventions are delivered at a crucial time, closely after an ICD
shock when stress is high, but PTSD has not yet developed. The specific aims are to: 1) examine the effects of
the SPSM intervention plus UC vs. UC alone on the primary outcome of ICD shock anxiety at 1 and 6 months
post-shock event, 2) describe the impact of SPSM plus UC compared to UC alone on the secondary outcomes
of total daily physical activity, depression, PTSD symptoms, QOL, salivary cortisol levels, and self-efficacy and
outcome expectations at 1 and 6 months post-shock event, and 3) assess feasibility, acceptability, and safety
of the SPSM intervention, SDOH will be used to describe differential responses to the SPSM intervention. This
study fills a significant gap in the care of patients with an ICD, through the systematic testing of a brief, novel
and cost-effective intervention that provides the knowledge and skills to improve quality of life. Study findings
will be used to design future larger RCTs to test intervention effectiveness for more diverse samples and
settings.

Public health relevance
Narrative This is the first test of highly promising biobehavioral intervention designed to optimize quality of life, reduce the development of psychological distress, and prevent PTSD for a highly vulnerable population of patients with an ICD who have received an ICD-delivered shock. Evidence of intervention effects will provide essential knowledge about patient outcomes and intervention feasibility and acceptance needed to conduct a larger RCT that will be required for broader dissemination of the intervention into clinical practice.